Leveraging Integrated liNked data to assess and optimize Child outcomes (LINC)

PROJECT SUMMARY
Children who are perinatally HIV exposed and uninfected (CHEU) have worse birth, mortality, infectious disease
and neurodevelopmental outcomes than children perinatally HIV unexposed (CHU). Given the scale of perinatal
HIV exposure in high prevalence countries, even small CHEU/CHU health disparities may have important public
health and societal impacts e.g., on overall child mortality, hospitalization, education, adult health and
productivity. While many CHEU may have expected health outcomes, a subset may be at risk of sub-optimal
outcomes potentially mitigated by targeted interventions. A paradigm shift is thus needed for vertical HIV
transmission prevention (VTP) programs that currently measure success as a child who is HIV free, to a
public health approach ensuring all children are HIV free with equivalent health outcomes. Integrated
surveillance with linked mother-child data is critical for a public health approach to 1) quantify and understand
IHEU outcomes and the impact of ever-evolving interventions to improve the health of pregnant people
with HIV or at risk of acquiring HIV and their children, and 2) identify those at high risk of sub-optimal
outcomes to ensure optimal patient-centered intervention delivery. Leveraging the strength of the NICHD-
funded (R61) CHERISH Provincial Health Data Centre (PHDC) in the Western Cape (WC), South Africa (SA),
the first comprehensive linked health information exchange in Africa, and considerable investments in
using routinely collected health service data to optimize health outcomes in Botswana and Kenya, we
will establish and enhance integrated platforms for CHEU/CHU surveillance with the following Specific Aims:
Aim 1: To use WC PHDC linked mother-child data (~1.3 million pregnancies; ~1 million live-born children from
2018-2029) to compare a) pregnancy and birth outcomes, b) infant/child outcomes up to age 5 years (mortality,
tuberculosis, infectious disease hospitalization), c) longer term (≥age 15 years) outcomes (e.g., reproductive
health) by maternal HIV and antiretroviral (ARV) exposure status, including long-acting ARVs. We will enhance
PHDC data by a) using artificial intelligence to improve exposure and outcome inference algorithms and b) linking
to detailed socio-economic data from an existing ongoing demographic and health surveillance study
Aim 2: To assess the utility of PHDC programmatic linked mother-child data to identify CHEU/CHU at high risk
of sub-optimal neurodevelopment, infectious disease and tuberculosis for delivery of targeted interventions.
Aim 3: To engage Botswana and Kenya Ministries of Health, leveraging existing interest in enhancing routinely
collected health data to co-create and pilot a toolkit/blueprint for linkage of programmatic mother-child data.
Developing CHEU/CHU population surveillance using mother-child linked data integrated with routine
health data will provide ongoing understanding of CHEU/CHU disparities in the context of evolving
interventions to address them and facilitate iterative improvement of maternal/child health programs to
address intervention gaps and maximize opportunities for all mothers and children to survive and thrive.